PITX HOMEOBOX GENE FAMILY IN CRANIOFACIAL DEVELOPMENT

Human development is a complex process involving multiple gene interactions at various stages of embryogenesis and with important environmental overlays. In the last few years, the role of transcription factors in early development and the impact that disruptions in these genes can have on normal structures has become increasingly evident. We have recently identified the human RIEG1 (PITX) gene as a novel bicoid- class homeobox gene responsible for Rieger syndrome, which has anterior chamber defects, dental hypoplasia and umbilical abnormalities as primary manifestations. A second member of this family (PITX3) has just been identified in our laboratory in which a mutation causes the disorder anterior segment mesenchymal dysgenesis (ASMD). In this proposal, we will expand our studies of these transcription factors, through identification of additional human craniofacial disturbances caused by abnormalities in these genes and by detailed studies of the genes developmental cascade. Specific goals of the project will include: 1) additional characterization of the Rieger class genes, including their DNA structure, the identification of new class members and of gene homologous to the recognized regulatory sequences. Further characterization of families and individuals, with a particular focus on those whose phenotype includes craniofacial anomalies will also be carried out; 2) expression-based studies will be performed that will included tissue-specific studies involving the mouse model; 3) the use of transgenic animals as a model systems for the study of epistatic interactions, including the development of knockout mice for two of the Rieger-class genes and the initiation of complementation studies using Rieger-related genes and genes with similar or complementary expression patters. The outcome of this project will be an expansion of our understanding of the causes of facial structural defects, as well as a detailed understanding of the developmentally biology of a new class of homeobox genes shown to be critical in development. Models will be developed that can be used for studies of gene-gene and gene-environment interactions to further our insights into basic biology, therapeutics and prevention. The correlation of expanded phenotypes with specific mutations and the ability to study these for gene-gene and gene- environment interaction affords a opportunity for a comprehensive understanding of a new class of homeobox genes for their role in human birth defects and adult disease. This project will directly interact with Project 3 (Russo) which will study protein-protein interactions of the PITX genes and interface with projects 4 and 5 and the clinical and molecular cores, as well.